California Monitoring of Early Childhood Autism (CA-MECA)

DESCRIPTION (provided by applicant): In response to CDC RFA-DD-07-007 (Implementing Surveillance to Determine Prevalence of the Autism Spectrum Disorders (ASD)...in Early Childhood Populations), we propose CA-MECA, to be conducted under the leadership of the California Department of Health Services (DHS) and in partnership with Kaiser Permanente of Northern California (KPNC), and multiple health and service providers in Santa Clara County (SCC), California. Our primary goal is to establish a scientifically rigorous, multi-source surveillance system to accurately determine the population-based prevalence of ASD in young children (<4 years old) for two birth cohort years (2005-2006) in SCC, which has ~26,000 births/year and a very diverse population. Doing so is relevant to CDC's goal to prevent birth defects and developmental disabilities and improve the health of people with disabilities. There are three components to the CAMECA proposal that reflect our specific aims: 1) To identify young children (<48 months) with possible or definite autism in the county born in the two target years, we will work with the local regional center for the developmentally disabled, community clinics, and specialty providers. Records will be abstracted to collect data to determine final surveillance case status by expert review and to describe characteristics of the children with ASD. Additional data will be obtained from birth certificates. Both current and birth residence prevalence estimates will be calculated. 2) To identify possible gaps in the surveillance system and to reach an under-served segment of the population, we will conduct routine screening for developmental disabilities and ASD in 18-30 month old children born in 2006 at two pediatric clinics that serve a lower income, primarily Hispanic population, with appropriate referrals for clinical evaluation. After linkage to the surveillance system, we will compare prevalence in the screened sub-group to those born in 2005 and seen at the same clinics but not screened, to evaluate completeness of overall prevalence estimates and to provide a more accurate estimate of prevalence in a Hispanic population. 3) To increase awareness and early referrals for autism evaluations, we will conduct outreach and education to general pediatricians and other relevant community groups, assembling and convening a community advisory board to assist us. The two data collection components include on-going quality control, and will be evaluated for completeness, accuracy and feasibility of wider application. Reports will be widely distributed. Data from the CA-MECA project will be valuable for obtaining accurate counts of young children with ASD to track changes over time, to plan and deliver services for affected children and their families, to uncover risk factors for ASD, and to identify underserved groups, as well as providing information to improve early screening and diagnostic practices.

Public health relevance
California Monitoring of Early Childhood Autism (CA-MECA) A. SPECIFIC AIMS Autism is a serious behaviorally-defined condition characterized by impairments in social interaction, communication, and behavior patterns, expressed variably along a spectrum of severity. A dramatic increase in the number of children identified with autism spectrum disorders (ASD) has been reported over the past two-three decades throughout North America, Europe, and elsewhere. To provide accurate prevalence rates useful for monitoring trends, it is important to implement standardized data collection, as organized by the Centers for Disease Control and Prevention (CDC) in the form of the Autism and Developmental Disabilities Monitoring (ADDM) network for surveillance in 8-year olds. As part of that network, our California Center for Autism and Developmental Disabilities Research and Epidemiology (CADDRE) team have considerable experience conducting ASD surveillance in the San Francisco bay area. Early intervention for children with signs of ASD has shown favorable results and thus increasing medical and public health resources are being devoted to early identification programs. To plan for the necessary services to meet the needs of affected children, it is important to understand ASD prevalence at younger ages. Complete and accurate ASD surveillance of children under four requires the development of a methodology that is different in key respects from that for older children because it will rely more on early screening tools and initial ASD evaluations. For the past six months, we have been working under an award from CDC to develop such a methodology and herein describe a proposal to implement it. Our goal is to establish a scientifically rigorous, multi-source surveillance system to accurately determine the population-based prevalence of ASD in early childhood (<4 years old) for two birth cohort years (2005-2006) in a large, diverse, urban population. To accomplish this goal, we have several specific aims: 1. Work with medical and educational providers and specialists in Santa Clara County, CA to identify and to collect epidemiologic data on children with diagnosed ASD or suspect ASD before the age of 48 months in order to derive population-based estimates of current year and birth cohort prevalence and describe characteristics of young children with ASD. 2. Conduct routine, early screening for ASD in two clinics that serve a low income primarily Hispanic population to assess the feasibility of routine screening, to evaluate and maximize the completeness of prevalence estimates, and to examine the reasons underlying the typically lower prevalence observed in Hispanics and low income individuals. 3. Provide educational materials to medical professionals, community groups, and parents to promote awareness of ASD, the importance of early identification, and the resources available in the community. This aim will contribute to the completeness of case ascertainment and to our ongoing partnerships with community providers and parent organizations. 4. Evaluate the surveillance system and screening project for accuracy and completeness of data and feasibility of application to other populations. B. BACKGROUND AND SIGNIFICANCE B.1. Overview of Autism Autistic Spectrum Disorders (ASD) are neurodevelopmental disorders characterized by impairments in three domains (social interaction, communication, and repetitive or stereotypic behavior) that vary in severity of expression1,2. Autistic Disorder is the most severe disorder on the spectrum which also includes Asperger's Disorder and Pervasive Developmental Disorder-Not Otherwise Specified (PDD-NOS). ASDs are believed to result from disruption of normal neurobiologic mechanisms primarily in the prenatal period and are widely recognized to have a strong genetic component involving multiple gene loci. The search for non-genetic risk factors has intensified in part to explain the dramatic increase in numbers of children diagnosed with ASD since the early 1980's2,3. Approximately 20-30% of cases experience regression, with onset between 18-24 months of age following a period of apparently normal development4. A number of other developmental and medical conditions are reported to commonly co-occur with autism, including some degree of mental retardation (40-55%), psychiatric symptoms, seizures, gastrointestinal problems, sleep disturbances, feeding difficulties, and immune system dysregulation2. In about 10% of children with autism, specific genetic, neurologic, or metabolic disorders are implicated etiologically. Support services are often required throughout life as most individuals with autism cannot live independently as adults5,6. The diagnosis of autism is based solely on behavioral criteria, as there are as yet no known biologic tests for the disorder. Current diagnostic criteria for ASD are defined by the Diagnostic and Statistical Manual of Mental Disorders, 4th Edition (DSM-IV) 1, including Autistic Disorder (DSM-IV 299.00), Asperger's Disorder (DSM-IV 299.80) and PDD-NOS (DSM-IV 299.80). Distinctions between these three diagnoses are based on the number and combination of criteria that are met in three domains: (1) qualitative impairments in social interactions, (2) qualitative impairments in communication, and (3) restricted, repetitive and stereotyped patterns of behavior, interests, and activities. Until recently, ASDs were typically not diagnosed until after 3 years of age, often with substantial delay between initial parental suspicion and final diagnosis. Refinement of tools for screening and diagnosis in routine clinical practice and in research is ongoing and diagnosis before 3 years of age is increasingly common. B.2. Prevalence of Autism Over the past 25 years, there has been a dramatic rise in the reported prevalence of autism, with much public debate surrounding the reasons for this increase. Early reports estimated prevalence at 4-5 affected children per 10,000 births7. Data published in the last few years suggest that Autistic Disorder occurs in at least 10-20 children per 10,000 births and the prevalence of the broader autism spectrum may be as high as 1 child in every 150 in the population, as recently reported from the ADDM network based on health and school records8,9,10. Our analysis using the California Department of Developmental Services (DDS) database demonstrated a 2.6-fold increase in prevalence of autism among children born in California between 1987 and 199411. More active case ascertainment, increasingly younger age at diagnosis, and an expansion of the diagnostic criteria likely play a role in the reported increase, so the magnitude of an actual increase in the incidence of ASD is difficult to determine. A consistent finding is a higher prevalence among males than females; the recent ADDM report showed a prevalence ratio of 3.4-6.5M:1F across sites. The ratio varies with severity of cognitive impairment, being lower among cases with severe impairment2. Prevalence may also vary by race/ethnicity, with rates consistently lower among Hispanic, or black, non-Hispanic children, than among white, non-Hispanic children10. The degree to which this is due to etiologic factors, demographic risk factors, or differing diagnostic patterns is currently unknown. B.3. Importance of Early Diagnosis When the ADDM/CADDRE surveillance network was established, data collected by the CDC in Atlanta indicated that eight years of age was the age of highest prevalence for children 3-10 years of age8. Since then, evidence has accumulated supporting the benefits of early intervention for improving long-term outcome12. Neuroscience investigations have demonstrated neuroplasticity of the brain during early childhood that is responsive to activity and experience, particularly within a context of social interactions. Diverse and complex stimulation during neurodevelopment is linked to cortical specialization; cortical specialization contributes to the increasingly complex brain circuitry necessary for coherent and flexible complex behaviors and integration of behaviors across developmental systems13. Clinical investigations have demonstrated that even in the absence of specialized intervention programs, improvements in cognitive and language skills in children with autism are more dramatic between the preschool years and middle childhood than from mid- childhood to adolescence14,15. A recent review summarized literature demonstrating an association between early intervention and gains in speech, language, and social development13. These factors have led to increased public awareness of the value of early screening, the development of early screening tools, and federally-mandated programs (most notably the Individuals with Disabilities Education Act (IDEA) Part C Program for Infants and Toddlers with Disabilities) to identify children 0-3 years of age at risk for developmental disabilities and provide early intervention services. In the ADDM multi-source surveillance system which included children born in the mid-1990's, the mean age at diagnosis was just over 4 years old10, although there were concerns about developmental delays before age 3 for a majority of the children. Other studies have also reported that a substantial proportion of parents voice concerns by age 2 or notice some developmental abnormalities in the first year, illustrating sometimes substantial delays in opportunity for intervention10,16,17,18. Recent data show that an experienced clinician can reliably diagnose autism in children as young as 2 years old19. The stability of an ASD diagnosis at age 2 has been demonstrated to be high when re-assessed later20,21. Since 2001, the American Academy of Pediatrics has recommended routine screening of all infants and young children for developmental delays22. The increasingly earlier age of typical identification of children with ASD presents the opportunity for development and implementation of an epidemiologic surveillance system for young children that can be responsive to etiologic/risk factor and service-related questions. B.4. Unique Opportunity in Santa Clara County We have been conducting multi-source ASD surveillance in six counties in the San Francisco Bay area under a cooperative agreement with the CDC (see section C.1). Santa Clara County (SCC) is included in this area and is the site of this proposed MECA project. In addition, the CDC CADDRE case-cohort study (called Study to Explore Early Development (SEED)) will be conducted in SCC, under the direction of our team, as part of a national multi-site protocol. We are thus very familiar with the ASD ascertainment sources in the area and have developed strong working relationships with these organizations and individuals, including the local regional center (SARC) of the statewide entitlement program (i.e. DDS). B.4.a. Population SCC is an urban/suburban county at the south end of San Francisco Bay with a large population of nearly 2 million residents and over 26,000 births/year. The adult population is generally well- educated (45% have Bachelor's degree or higher) and almost half of employed adults are engaged in managerial/ professional occupations (US Census), many in computer-related fields. The population is strikingly diverse with regard to race/ethnicity. From the 2000 census, 57% of the adult population identified themselves as White, another 30% as Asian, and 2-3% as black or African-American. About 30% of residents also identified themselves as of Hispanic ancestry. Of great relevance for surveillance of young children with ASD, the county has a very well- established and well-integrated system of diagnostic and support services for young children at risk of developmental disabilities, including ASD. Parents in the community expect quality services and demonstrate their support through active participation in advocacy groups. B.4.b.Established networks and contacts There are many collaborative networks and task forces already in place in SCC that will be instrumental in helping to implement our comprehensive system to monitor ASD in young children. We have good relationships with the members of these groups and have garnered letters of support from many for this proposal (see letters and D.4). Examples of collaborative efforts emphasizing local interests in ASD are described here: ASD Center, Kaiser Permanente Northern California (KPNC): The Kaiser Permanente Medical Care Program is the country's largest and oldest group model pre-paid, integrated health plan. KPNC covers 14 counties, and members represent 25% of births in SCC. KPNC established the Regional ASD Program in 2004, directed by Pilar Bernal M.D., that represents over sixty clinicians in child psychiatry and pediatrics and maintains two ASD specialty clinics, one in SCC. KPNC provides routine autism screening for children aged 18-24 months during well-baby check-ups, allowing pediatricians to refer young children who they suspect may have autism to a KPNC ASD Center. Once a child is referred, a multidisciplinary team evaluates and diagnoses the child and develops and coordinates an individual treatment plan. The KP ASD Clinical-Research Partnership is a unique program dedicated to monitoring outcomes, evaluating service utilization, and investigating etiologic factors and treatment approaches for individuals with ASD in the KPNC population. A team of experienced researchers at the Kaiser Division of Research (DOR), led by epidemiologist Lisa Croen, PhD (a co-investigator on MECA), collaborates with the Regional ASD Program to track trends in diagnosis, service utilization, costs, referrals, and patient and provider satisfaction. Several studies underway provide an opportunity for KPNC patients to contribute to research. ASD Collaborative, SCC: This growing collaborative has members from the KPNC ASD Center, SARC, KidScope/KidConnections, and the SCC Special Education Department. This group 1) provides assessment, consultation, and treatment of children, and their families from a developmental, multidisciplinary, and best practices perspective; 2) maintains a commitment to early identification and treatment of ASD; 3) educates, supports, and empowers parents through interventions that are evidence-based; and 4) educates care providers who work with children throughout SCC service agencies. 2005 SCC Children's Report: Key Indicators of Well-being23: This report, created by a broad base of health, education, social services, and community-based organizations, identifies ASD research and surveillance as "critical areas where valid and reliable data are needed, but are not available". Excerpts from the report state that "Currently, there is not an effective way to measure the prevalence of disabilities and special needs. We are also unable to track at what point in a child's life these special needs are identified. Establishing a system to track this information has the potential to improve interventions and help children thrive" (p.31). B.5. Significance and Innovation Autism is a very serious, typically lifelong disability that affects entire families. The numbers of children diagnosed and receiving services for autism has increased greatly in the last few decades, generating a need for more medical and educational services. Costs for families, the health care system, and the educational system can be staggering. At an occurrence rate of 6-7/1000 and with 500,000 births/year, California alone may be experiencing 3000-3500 new cases annually. The lifetime per capita incremental societal cost of autism has recently been estimated at $3.2 million6. Surveillance in young children is critical in order to anticipate resource needs, as well as to evaluate the success of early screening and intervention programs. The observed increase in frequency has also led to greater professional and public interest in identifying the causes of ASD. Therefore, identifying cases at younger ages, closer to the time of pathogenesis, would permit better evaluation of possible lifestyle/environmental factors, and thus contribute importantly to the formulation of effective prevention strategies. Due to our extensive public health experience in establishing a successful ASD surveillance system for older children, as well as our many years of collaboration on numerous research studies on the etiology of autism, our team is uniquely qualified to implement a sustainable, active surveillance system for ASD in young children Our proposed population-based surveillance system will incorporate new methodologies necessary to address diagnostic differences in younger children and will efficiently provide high quality data in a timely manner. The routine developmental screening we propose to conduct in a segment of the population that would generally be underserved, e.g. low income, predominately Hispanic children, will provide new data to assess feasibility of early screening in such a population, evaluate the impact of routine screening on age at diagnosis and intervention, and generate a more complete estimate of ASD occurrence in Hispanics. Our team's epidemiologic and health education expertise will be complemented by active partnerships with local clinicians, providers, and parent organizations to assure successful implementation. C. PRELIMINARY STUDIES C.1. ASD Multi-source Surveillance among 8-year olds C.1.a. Background In 2001, we were funded under the CDC CADDRE/ADDM program (Dr. Grether, PI) to conduct multi-source, active surveillance of eight year old children in a 6-county area surrounding San Francisco Bay with approximately 80,000 births per year. Our case ascertainment sources include the statewide entitlement program operated through the Department of Developmental Services (DDS) and its local Regional Centers (RCs), Kaiser Permanente of Northern California (KPNC), hospital and community-based clinics, and specialist private providers. In our surveillance system we determine a prevalence estimate for children with DSM-IV ASD identified anytime prior to their 9th birthday, based on residence at birth in the 6-county catchment area. We gave priority to a birth prevalence because it is unaffected by migration of affected families into the catchment area to obtain services for their disabled child and potentially provides more relevant data for examining prenatal risk factors. However, the ADDM model10 is based on current residence, which is considered more appropriate for planning service needs. C.1.b. Methods Ascertainment Sources: We had access to data on individuals enrolled in DDS/RC, KPNC, all 8 hospital-based specialty clinics (autism/PDD or child development), 2 community-based clinics, and close to 50 private providers, without the need to obtain individual consent for record review for surveillance purposes. Only two providers opted to obtain verbal consent over the phone from parents and one other refused cooperation, demonstrating the success of our approach. A brief description of the two major ascertainment sources follows. California Department of Developmental Services (DDS) and Regional Centers (RC) The California DDS operates a statewide system of 21 Regional Centers that coordinate services for persons with autism, mental retardation (MR), and other developmental disabilities (DD). RC eligibility is determined and services are provided without regard to citizenship or financial status. The system is widely utilized across different socio-economic levels and racial/ethnic groups. Referrals come from pediatricians and other clinical providers, the educational system, friends, and family members. We have an MOU with DDS (Appendix A) that allows us to review hard copy files at the RCs as well as centralized statewide electronic records without individual consent so we can abstract data on children being served anywhere in the state. For individuals 36 months of age or older (and for some clients <3 years of age), DDS maintains a centralized electronic database of diagnostic and identifying information, derived from information provided by the RCs on a standardized, statewide reporting form (Client Development Evaluation Report (CDER) -Appendix B). Children at the milder end of the ASD spectrum are not considered eligible for services at most Regional Centers. In addition, reliance on CDER diagnostic codes alone may result in under-ascertainment among clients because only one qualifying condition is required for DDS/RC eligibility, so some children may be coded with an accompanying disorder to ASD. Our prior work has shown that DDS serves 80-85% of children with autistic disorder, but a lesser (unknown) proportion with other ASDs11. Kaiser Permanente of Northern California (KPNC) Kaiser members represent 25% of the live births in the 14-county Northern CA region and can receive most of their prenatal and pediatric care through KPNC professionals (see B.4.b as well). Although most members enroll through employment, many also join through MediCal (a low- income health insurance plan). Analysis of California data demonstrates that KPNC members are representative of the general population with regard to sociodemographic characteristics24, with the exception of Hispanic ethnicity, which is somewhat under-represented, and maternal college education, which is somewhat overrepresented. The KPNC has a number of automated databases including inpatient and outpatient records containing detailed information on all diagnoses and procedures from hospitalizations and ambulatory visits. These data resources add significant value to the proposed study, and are reviewed under the direction of Dr. Lisa Croen, co-Investigator, at the KPNC Division of Research. With consultation from Dr. Pilar Bernal, Child Psychiatrist and Director, KPNC ASD Center, we developed a computer algorithm using ICD-9 codes and text strings recorded in the KPNC outpatient data base to identify children to review for a diagnosis of ASD. Data Collection Methods: We attempted to identify all children diagnosed with ASD before their ninth birthday born in 1994 (and 1996 for an additional birth cohort year) in one of the six San Francisco Bay Area counties. Working with ascertainment source electronic data files or with ascertainment source personnel, CA CADDRE staff compiled a list of potentially eligible children diagnosed with ASD, as well as children diagnosed with selected other neurodevelopmental disorders, including mental retardation. Birth residence in the area was determined by probabilistic linkage to CA linked vital records files representing live births that survived to age one. Demographic information was obtained from birth certificates. Following a protocol initially developed by the CDC8, and adapted to our ascertainment sources, trained medical record abstractors reviewed and abstracted detailed diagnostic and clinical data from records at the ascertainment sources, if ASD behaviors were present. Final case status was determined by computer algorithm and several levels of expert review. Confirmed cases meet one of the following criteria: ¿ A diagnosis of ASD based on DSM IV criteria from a qualified medical professional per a pre- identified list of specialists, ¿ Qualification for Special Education under an Autism Exceptionality, or ¿ Autistic behaviors that meet DSM-IV ASD criteria, per expert clinician review. In addition, expert review yielded a category of: ¿ Suspected Case: Some evidence, but child would need to be evaluated in person by DSM IV criteria to confirm diagnosis We conducted a number of quality control procedures using sample records during training and a check on a 10% sample of actual records to compare the work done by abstractors to that done by a senior staff person in order to evaluate the original decision to abstract (or not abstract), as well as the completeness and accuracy of the abstracted data. Additional checks of the birth certificate linkage were also conducted. We designed a database, called TWEEN, to capture data from our multi-source surveillance effort, including identifiers and diagnostic assessment variables (see Appendix C). TWEEN also enables us to track subjects at each ascertainment source and to include multiple records per subject. C.1.c. Surveillance Results Data provided here have not been reviewed nor approved by the ADDM/CADDRE network and are presented for purposes of application review only, not for release or disclosure outside of the grant review process. Because we are calculating birth prevalence, CA-CADDRE data were not pooled with other ADDM sites in their recent report10. About 82,000 children born in the region and surviving to age one comprise the denominator for our prevalence estimate. Over 1000 source records were reviewed and 650 records abstracted for 456 children (0.5% of total population). Of these, 384 met the criteria for a confirmed case (see above), yielding a prevalence rate of 4.7/1000 births (table 1). An additional 33 were suspect cases, yielding a prevalence of 5.1/1000. Focusing on confirmed cases, males were nearly six times as likely as females to be affected (table 1). By race/ethnicity, Asians and white, non- Hispanics were similarly affected, but Blacks and Hispanics had lower prevalence estimates, which persisted after adjustment for parental age and education, and child gender. Table 1: ASD Prevalence Estimates (per 1000 livebirths) for 1994 Births, San Francisco Area N % Prev 95% CI Total Cases 384 4.7 4.2 - 5.2 White, Non-Hispanic 200 52.1 6.0 5.1 - 6.8 Black, Non-Hispanic 26 6.8 3.2 1.9 - 4.4 Other Race/Ethnicity 158 41.1 3.9 3.3 - 4.5 Asian, Non-Hispanic 57 14.8 5.3 3.9 - 6.7 Other Race (non-Hispanic) 39 10.2 5.6 3.8 - 7.3 Hispanic (regardless of race) 62 16.1 2.8 2.1 - 3.4 Male 329 7.8 7.0 - 8.7 Female 55 1.4 1.0 - 1.7 Among our cases, 70% were served by DDS; an additional 20% were unique to KPNC and 10% were identified from private providers only. Of the children served by DDS, 82% had an autism diagnosis on their CDER while the remaining 18% had a diagnosis of MR or other DD. The prevalence of ASD calculated among Kaiser members in the surveillance system is higher than overall at 7.1/1000. This does not appear to be due to any major differences in population demographic characteristics, but might be hypothesized for several reasons: more awareness among clinicians, better access to diagnostic services, or less out-migration and thus increased ability to track members within the KPNC system. C.1.d. Conclusions Our prevalence estimate, although a birth prevalence, which may be lower than current prevalence due to out-migration, is in the range reported recently from other sites in the ADDM network, e.g. 3.3 -10.6/1000 8-year olds for the same birth cohort10. The KPNC prevalence estimate is very similar to the pooled estimate for ADDM. Our sex ratio was consistent with those observed in ADDM data and our race patterns were similar, although we have a much larger proportion of Asians than other sites and can thus provide more stable estimates. We have completed data collection and nearly completed final quality control procedures for surveillance of children born in 1996 from the same catchment area, and are finding a similar number of cases. We decided to report results for both birth years in one document. It is notable that we have achieved, within the first CDC cooperative agreement, complete multi-source surveillance of two birth cohort years for a catchment area that is 2-3 times as large as that in other ADDM projects. To a large extent, our success in establishing a comprehensive multi-source surveillance system with comparable prevalence figures to those reported elsewhere using intensive methods8,9,25 is due to our access to large electronic data bases, authority to review records in both the DDS/RC and KPNC systems without the requirement to obtain individual consent, the comprehensive nature of the information in these records, and our community outreach efforts. C.2. MECA Planning Grant C.2.a. Overview/Summary In response to the CDC/ NCBDDD RFA issued in November 2005 entitled "Developing Methodologies to Determine the Prevalence of Autism Spectrum Disorders in Early Childhood and Young Adult Populations", our California team applied for and was awarded a one-year planning grant to design an ASD surveillance system for children <4 years of age in SCC. Our proposal stipulated that we would adapt the multi-source surveillance methodology we had previously used for 8-year old children to include providers, data bases, data elements, and case definitions appropriate for children in this younger age group. We have engaged in an inclusive process with our ascertainment sources and community groups to appropriately adapt the methodology and to evaluate the feasibility for implementation. To that end, over the past 7 months we have undertaken an intensive effort to understand the complex and evolving service system for young children at risk of ASD in SCC. We have developed and deepened our partnerships with the numerous providers who serve these young children, some of whom did not participate previously due to the young age of their clients or because they have only recently begun providing screening and assessments in SCC. We have a commitment from all of the primary ascertainment sources to work with us over the next four years to implement this grant. One of the exciting challenges will be to stay current with new providers, practices, coalitions, data bases, and support organizations. Individuals from key organizations will work with us on a regular basis to ensure the surveillance system is implemented successfully and will participate in advisory group meetings that we will convene. To summarize our accomplishments to date, we have: 1. Identified case ascertainment sources and mapped out the complex referral pathways for young children with developmental concerns in SCC (see Appendix D); 2. Identified existing electronic and manual data bases and logs for initial case finding, and the data elements available; 3. Identified and developed collaborative relationships with providers whose evaluations and services are limited to young children and re-focused our existing relationships with other providers towards surveillance of young children, eliciting their support (see letters of support). 4. Identified community-based clinics that provide pediatric care for low-income, primarily Hispanic, children in SCC and do not currently use any standardized early developmental screening instruments. After numerous discussions with clinic staff, we have worked out an agreement for administration of a standardized general developmental screener and an ASD screener for children who are 18-30 months of age, born in 2006. 5. Conducted pilot analyses at our two largest case ascertainment sources, Kaiser Permanente and IDEA Part C Early Start program (see below). In addition, we have successfully negotiated agreements with these two primary case ascertainment sources to maintain real-time data bases for us on children in our birth cohort years who are in their system with red flags for ASD. This will ensure efficiency in data collection for surveillance and reduce costs. 6. Worked closely with key local providers to evaluate the feasibility of implementing a multi- source surveillance system for young children in SCC over the next four years and to determine the funding that would be required to assure efficient, complete, and accurate data collection on children at risk of having an ASD. C.2.b. Pilot Data from Early Start Record Review Under state law, the DDS system and its local RCs have the responsibility to plan, develop, implement, and monitor the statewide intervention services system for children 0-3 years of age (Individuals with Disabilities a...